A glycolipid adjuvant to promote dose sparing, accelerate immunization schedules and extend durability of high-level protection with an attenuated, live sporozoite malaria vaccine

We propose to further enhance Plasmodium falciparum (Pf) Sporozoite (SPZ)-based vaccines
against malaria that are the only immunogens proven to induce >90% short term (3 weeks) and long
term (at least 14 months) protection against controlled human malaria infection with Plasmodium
falciparum (Pf) in humans. Using a unique glycolipid adjuvant 7DW8-5, the goal is to prolong the
duration of vaccine efficacy (VE) and to increase efficacy in endemic settings. In the mouse model
using P. yoelii (Py) sporozoites (SPZ) we achieved > 80% protection at 16 weeks with 2 dose and 4
dose accelerated regimens of irr PySPZ plus 7DW8-5 adjuvant administered by direct venous
inoculation (DVI) representing a 2-fold enhancement over irr PySPZ without adjuvant. The adjuvant
could be mixed with irr PySPZ. High level (>80%) protection of mice persisted at 16 weeks with irr
PySPZ by DVI, in the presence of 7DW8-5, but not by non-DVI routes. Manufacturing of 7DW8-5
under cGMPs was completed and in a pilot study with P. knowlesi (Pk) SPZ, irr PkSPZ we achieved
50% VE and no improvement with the adjuvant, likely attributable to sub-optimal comparative dose or
dosing regimens, or the short-term infectious challenge design. Due to the excellent demonstrable
safety record of the combined SPZ-adjuvant vaccine in NHPs, and comparable bioactivity on co-
culture human iNKT cells in vitro, we propose further optimization of dosing regimens for durable
immunity in pig-tailed macaques, the natural host for Pk, along with protection studies to assess
adjuvant effects on chemically attenuated (PySPZ-chemoprophylaxis vaccine CVac) and genetically
attenuated (PySPZ-LARC) in mice. Using humanized HISA2/ hCD1d mice possessing functional
human CD8+ T cells and human iNKT cells (cellular targets of 7DW8-5) we will investigate whether a
PfSPZ-7DW8-5 combination immunogen can enhance the human CD8+ T-cell response to PfSPZ.
Adjuvant-associated biomarker discovery studies are also planned in mice. Towards clinical use of
the PfSPZ-7DW8-5 combination vaccine, we will establish stability criteria and formulation
methodologies for 7DW8-5, and further comparability testing of GMP-grade 7DW8-5 for bioactivity in
vitro as a lot release attribute and humanized HISA2/ hCD1d mice in vivo, compile a pre-IND package
in preparation for pre-clinical and clinical evaluation of the safety and efficacy of 7DW8-5-PfSPZ
combinations, and manufacture GMP 7DW8-5 for clinical use. Because studies outlined in this project
will be conducted with clinical grade, well characterized 7DW8-5, a positive outcome in our studies
will place us in a position to rapidly design and conduct formal pre-clinical toxicology and/or
biodistribution studies in compliance with FDA mandates for a speedier path to the clinic. Completion
of this project will mark the first development of an adjuvant for a live eukaryotic parasite vaccine.

Public health relevance
Project narrative In our screens to identify an adjuvant that can promote dose sparing and prolong duration of protection with an attenuated malaria vaccine, a novel glycolipid, 7DW8-5 that binds CD1d, and stimulates iNKT cells, was the only agent over several TLR ligands tested, to demonstrate significant enhancement in a mouse malaria model. We propose further pre-clinical characterization of adjuvant activity in mice and primates, to support its inclusion with Sanaria’s radiation-attenuated PfSPZ Vaccine in order to significantly enhance vaccine potency, efficacy and feasibility of use.